Evaluation of ViewMind's ability to detect beta-amyloid and tau burden consistent with Alzheimer's disease in persons with MCI using Machine Learning, VR, and eye-tracking technology

PROJECT SUMMARY
Alzheimer’s disease (AD) is the most common form of dementia which starts with gradual and wide-ranging
cognitive and functional impairments mostly in people aged above 50 years. The initial phase of the disease is
characterized by mild cognitive impairment (MCI). However, it is difficult to accurately distinguish between MCI
caused by AD and MCI due to other causes using current neurophysiological assessment. MCI due to AD
presents amyloid beta (Aβ) and tau depositions in the brain which can only be efficiently diagnosed by Positron
Emission Tomography (PET) and cerebrospinal fluid (CSF)- procedures that are expensive, invasive, and
complex4. The existing regular screening methods for early detection have limitations like limited scalability and
accuracy. Since the failure of the standard of care for AD is largely due to multifactorial etiology and difficult-to-
diagnose heterogenous clinical manifestations. Overall, there is a critical need for non-invasive, cost-effective,
and rapid diagnostic tools that can accurately identify MCI due to AD at its earliest stages and measure functional
impacts across cognitive domains, enabling timely interventions and the ability to monitor and quantify their
effects. ViewMind is a digital health and artificial intelligence company that provides clinically validated solutions
for precision diagnostics of neurocognitive disorders. ViewMind leverages ocular digital phenotyping, a head-
mounted display (HMD), and machine learning (ML) to enable the early diagnosis of MCI due to AD, offering a
non-invasive, cost-effective, and rapid method for precise measurement of multiple cognitive domains and their
related brain regions. ViewMind’s eye-tracking technology evaluates eye movement responses across a series
of cognitive tasks, collectively known as ViewMind Atlas AD exercises, within 15-20 minutes. The solution will
incorporate multiple cognitive exercises tailored to assess specific domains and brain functions including the
visual short term memory binding test (VSTMB). In this SBIR project, ViewMind will leverage data from the Bio-
Hermes-002 study to develop and validate ML algorithms for both the early detection of MCI due to AD and the
quantification of the functional impact on cognitive domains to measure the effects of early intervention. The
specific aims of the current proposal are (i) Development of an ML algorithm using ViewMind Atlas AD exercises
data to accurately classify participants into correct subject cohorts and (ii) Validation of the algorithm in classifying
participants into correct subject cohorts in a double-blind study. After validating their technology in Phase I,
ViewMind will validate the technology in clinical trials; followed by pursuing a Breakthrough Device Designation
as its regulatory strategy.

Public health relevance
PROJECT NARRATIVE Despite the advances made so far, diagnosing cognitive impairments leading to Alzheimer's disease in clinical practice can be challenging due to loopholes in the existing diagnostic regimen. ViewMind is combining eye- tracking technology, a head mounted display, and machine learning in developing a tool for the early diagnosis of Alzheimer’s disease at the Mild Cognitive Impairment stage itself.